Investigating the Relationship Between Age-Related Hearing Loss and Loneliness Among Community-Dwelling Older Adults

PROPOSAL SUMMARY
Significance: Loneliness has become a public health imperative given mounting evidence of associated
morbidities when it is not addressed, including increased risks for Alzheimer's disease and related dementias
(ADRD). Over 40% of older adults are estimated to suffer from loneliness, further underscoring the pressing
need for study. In February 2020, the National Academies recommended more research into known risk factors
of loneliness to inform novel screening and intervention strategies. One particular risk factor, hearing loss (HL),
affects two-thirds of all adults over the age of 70 years in the United States and is projected to increase by an
estimated 70% over the next four decades. The proliferation of HL can exacerbate distal outcomes like ADRD
that are associated with loneliness. Current loneliness interventions have shown limited efficacy, and the vast
majority do not clearly address HL. As a potentially modifiable risk factor, studying HL's relationship with
loneliness will add to the evidence base and contribute to developing effective solutions. This training proposal
supports the applicant's long-term goals to promote healthy aging through improving understanding of hearing
health and its role in facilitating healthy social connections. The proposal will lay the groundwork for a program
of research established using the NIH Stage Model for Intervention Development as a guiding framework.
Specific Aims: Through a sequential explanatory mixed methods design, we aim to: (1) Examine pure tone
audiometry's association with loneliness and hearing handicap as a moderator, (2A) Describe perceptions and
experiences of loneliness and hearing handicap among older adults with HL, and (2B) Integrate data from aims
1-2A to explain the contributing roles of HL and hearing handicap to loneliness.
Approach: Aim 1 involves multivariable adjusted logistic regression models examining additive and
multiplicative interactions from hearing handicap scores reported through a validated survey on the association
between a gold standard measure of HL (audiometry) and loneliness (Three-Item UCLA Loneliness). Methods
include secondary analyses of population data from a community-based, racially/ethnically and regionally diverse
older sample. Aim 2A involves analyses conducted via recommended guidelines for Qualitative Description with
data collected from theoretically-guided interviews with purposively sampled community-dwelling older adults.
Aim 2B involves using joint displays arraying quantitative and qualitative data to explain thematic findings.
Fellowship Training: As the first audiologist in the PhD program at Johns Hopkins Nursing, the proposed
transdisciplinary training will prepare the applicant through rigorous coursework, professional development
activities, and mentored research experiences to successfully complete the aims of this proposal and advance
the findings into subsequent innovative translations as a clinician scientist and leader in gerontology.

Public health relevance
PROJECT NARRATIVE Loneliness afflicts over 40% of older adults and evidence increasingly reveal associated insidious outcomes like Alzheimer's disease and related dementias. In February 2020 the National Academies recommended rigorous studies of potentially modifiable risk factors of loneliness like hearing loss (HL) to inform evidence-based screenings and interventions that promote healthy aging. Loneliness and its associated outcomes may likely proliferate given the projections of HL cases increasing by an estimated 70% over the next four decades, thus raising the imperative of understanding the relationship between HL and loneliness.